Regulation of T Cell Signaling: Structural Studies of PLCgamma1

DESCRIPTION (provided by applicant): In response to signal initiation at a number of different extracellular receptors, phospholipase C (PLC) hydrolyzes phosphatidyl inositol (4,5)bisphosphate (PIP2) to inositol 1,4,5-trisphosphate (IP3) and diacylglycerol (DAG). In turn, IP3 and DAG control calcium flux, PKC activation and activation of the Ras-Raf-MEK-ERK pathway. In spite of the importance of the PLC enzymes, there is a significant gap in our knowledge regarding the molecular determinants that control PLC function. The two aims in this revsed application focus on the regulation of a single isoform of the phospholipases, PLCγ1, in the context of signaling downstream of the T cell receptor. The PLCγ1 isoform contains a number of Src homolgy domains that have been implicated in regulation of PLCγ1 activity. The precise mechanism of regulation is not known. In our preliminary data we present a number of new findings that provide exciting insights into how the Src homolgy 2 (SH2) domains of PLCγ1 function to control phospholipase activity. Following T cell receptor stimulation, PLCγ1 is phosphorylated by the Tec family kinase Itk. We describe an unprecedented substrate docking mechanism that involves a direct interaction between the kinase domain of Itk and the carboxy-terminal SH2 domain of PLCγ1. This protein-protein interaction is required for phosphorylation of Y783 in PLCγ1 by Itk. Quite interesting is the fact that the interaction occurs in a phosphotyrosine-independent fashion;not the expected result for an SH2 mediated binding event. Further preliminary data show another noncanonical SH2 interaction whithin PLCγ1 that inhibits the substrate docking interaction with Itk. The structural details of these regulatory complexes will be elucidated during the course of the proposed work and the results transferred into functional assays to develop a molecular level understanding of PLCγ1 function. Given the non-canonical nature of the observed SH2 mediated interactions we expect that completion of the proposed aims will be particularly useful in properly dissecting the role of PLCγ1 in T cell signaling. To date, biochemical and cell biological probes into the role of the SH2 domains in controlling PLCγ1 mediated signaling have been limited to traditional 'loss-of-funtion'mutations that only disrupt canonical phosphotyrosine recognition. PUBLIC HEALTH RELEVANCE This proposal aims to understand specific molecular events leading to activation of the immune response. The molecules that will be studied are prime therapeutic targets for modulating an immune response in the context of disease. Thus, the public health relevance of the project relates to developing new ways to either limit or enhance the immune response in the face of autoimmunity, immunosuppression or immunological diseases.